Centering Patients: Development of a Tailored eHealth Intervention to Improve the UF Patient Experience

ABSTRACT
Project 3, entitled “Centering Patients: Development of a Tailored eHealth Intervention to Improve the
UF Patient Experience”, focuses on understanding the drivers of racial disparities in UF care and developing
an individually-tailored intervention to improve patient experiences. As with the overall Center, this project will
be guided by the principles of Community-Based Participatory Research under the direction of our Community
and Stakeholder Advisory Board. Our preliminary data from Black patients with UF indicate that they are often
dissatisfied with both their own understanding of UF as well as the care they receive. They want to be at the
center of their care. Interventions are needed that support patient autonomy and move toward a more patient-
centered care model. The overall objective of Project 3 is to conduct formative work to understand the
knowledge, attitudes, norms, beliefs, emotions, and lived experiences of Black women with UF and use these
insights to develop an individually-tailored digital tool to optimize UF care for future implementation and testing.
The digital tool will also convey key patient-reported information to providers to ensure that they are aware of
patient knowledge gaps, emotions, treatment preferences, and reproductive plans. To achieve this, we
propose three Aims:1) Quantitatively explore knowledge, attitudes, beliefs, and behaviors around uterine
fibroids as well as reproductive health more broadly amongst U.S. Black and White women; 2) Qualitatively
explore experiences of UF patients and providers; and 3) Develop an individually-tailored, interactive eHealth
intervention to increase knowledge, mitigate barriers, improve self-efficacy, and facilitate optimal patient-
provider communication. Project 3 will develop a culturally-tailored, personalized intervention that we believe
will decrease disparities in the fibroid patient experience that significantly and negatively impact Black women.
However, once created, the individually personalized tool will improve the uterine fibroid patient experience
generally - positively impacting all women.